2nd Biennial ASBMB - BSC Symposium on the Interplay between Epigenetic Regulation and Genome Integrity

Abstract
Over the past few years, it has become increasingly important to understand how epigenetics and chromatin
states impact DNA replication and DNA repair, two key processes critical for maintaining genome integrity.
However, most meetings on epigenetics and chromatin focus on transcription, while most meetings on DNA
repair or DNA replication include little attention to epigenetics and chromatin. The major focus of this meeting
will be the dynamic interplay among chromatin, including histone modifications and high-order chromatin
structure, and processes related to genome integrity, including DNA replication, DNA repair and the damage
response and is the only meeting dedicated to this subject. Moreover, the meeting also highlights how the
interplay between epigenetics and genome stability goes awry in cancer and aging cells. Therefore, this
conference will bridge this gap to link researchers who are interested in epigenetic regulations and chromatin
with those who are interested in genome integrity. The goal of this conference is to bring together scientists
who are interested in epigenetic regulation and genome integrity together for discussion and interactions. A
primary objective is to transfer knowledge and foster collaboration between basic academic researchers,
clinical scientists, and industrial researchers to understand how epigenetic states regulate genome stability and
vice versa, and how this goes awry in a diverse set of cancers and age-related diseases. In addition to the
scientific focus, we will promote interactions between two societies, the American Society for Biochemistry and
Molecular Biology (ASBMB) and the Biophysical Society of China (BSC). A second objective is to foster the
development and interests of younger investigators to help support their career development. The participants
stay and eat at the meeting venue, so they have ample time for informal brainstorming and networking. While
we have two outstanding keynote speakers and other field leaders that have already committed to speak, most
of the talks will be chosen from the submitted abstracts, enabling junior scientists to be highlighted in talks.
Further, the meeting will provide an opportunity for poster prize winners to give a short presentation, which is
important for their career development. We will also have a panel discussion on professional development and
career options, aimed to provide further support for the young investigators. Moreover, there will be a diversity
networking session, and multiple meet the speaker sessions that will be highlighted at the meeting. This
meeting is particularly timely because of the linkage between epigenetics therapeutics, genome stability and
cancer. The first joint conference of the two societies, ASBMB and BSC, was held in Suzhou, China in 2019
and was very successful attended by 275 scientists from all around the world, and we look forward to holding
the conference in Seattle, WA, USA on Sept 28-Oct 2nd in 2022.

Public health relevance
Narrative – Public Health Significance Increasing evidence points to the dysregulation of the epigenome, and the resulting changes in genome stability as a key driver of cancer and age-related diseases, a process that may be reversible by therapeutic intervention. Central to controlling the epigenome are histone modifying enzymes, ATP-dependent chromatin remodelers, and histone chaperones and our understanding of how these proteins control genome integrity is exponentially increasingly. These proteins play known roles in cancer, metabolic diseases, and aging and new therapeutic approaches, dietary interventions, and chemoprevention studies are under active investigation.